Intuitive Child Safety Seat to Increase Security

Project Summary/Abstract
Minnesota HealthSolutions Corporation (MHS) proposes to develop a child safety seat with a novel intuitive
harness tensioning system to improve the rate of proper harnessing of children into child safety seats. Children are
harnessed into child safety seats via a 5-point harness with shoulder straps that buckle at the crotch. The entire
harness assembly must be properly tensioned to ensure safety. Loose harnesses are a common misuse in child
safety seats. Several large studies have observed that only 10% to 20% of children are correctly harnessed into
correctly installed seats. Improper use of child restraints substantially reduces their effectiveness and is a major
public health concern. The proposed child safety seat will utilize an all mechanical, intuitive system to improve
proper use of the child safety seat harness. We hypothesize that a child safety seat that provides an intuitive and
easy-to-use harness system will significantly improve the rate of proper child safety seat usage and reduce vehicle
crash-related child injuries and deaths. An interdisciplinary team of researchers has been assembled to define,
build, and evaluate a prototype system.

Public health relevance
Project Narrative Motor vehicle crashes are a leading cause of unintentional morbidity and mortality among children in the United States and a leading cause of brain injury. A total of 3,355 children ages 0 to 8 died as an occupant in a motor vehicle crash from 2016 to 2020 and hundreds of thousands more had injuries that required treatment. We aim to develop a significantly easier to use intuitive harness tensioning system that improves child safety seats and better protects children riding in motor vehicles.